IMSD at Indiana University School of Medicine through Inclusive Biomedical Research Training Program

The Indiana University School of Medicine (IUSM) is host to nine doctoral programs that share a
common admissions process, entry point, open enrollment, and a core curriculum. The IUSM
Graduate Division has committed significant resources and focused effort in order to increase the
diversity of our applicant pool and enrolled students. The ultimate goal of these efforts is to support
a healthy and vibrant biomedical research enterprise. To catalyze the success of our trainees it
is critical that we create new programming that directly address professional development, robust
mentoring structures, and wellness with an equity and inclusion lens. It is with this in mind that we
propose to establish the IMSD at Indiana University School of Medicine through Inclusive
Biomedical Research Training Program. The central mission of IMSD at IUSM Training Program
will be to provide graduate students with a holistic training experience that enriches their technical,
operational and professional skills. The specific goals of the program include to increase the
number of students that obtain independent fellowships, increase PhD completion rates, decrease
time-to-degree, and provide transferable curricular content. This will be accomplished by
establishing a multi-level mentoring framework that incorporates both professional and peer
mentoring, leveraging programming focused on grant proposal writing, creating curricular
programming on bioinformatics, and establishing robust training for the participating faculty that
that includes elements of career development and of diversity, equity, and inclusion. Strategic
and intentional career development will also be integral to the IMSD at IUSM Training Program.
Through workshops, experiential opportunities, career coaching and communities of practice,
trainees will explore career options, acquire key professional skills, and gain the self-efficacy
needed to establish a successful and fulfilling career path. The ISMD at IUSM Training Program
brings together 41 participating faculty mentors that represent the various doctoral programs and
a diversity of key integrated areas of biomedical research. Importantly, the IMSD at IUSM Training
Program affords considerable institutional support and partners with the Graduate Division, the
Office of Diversity Affairs, and the Indiana Clinical and Translational Sciences Institute to build a
supportive and inclusive training experience. Altogether, the IMSD at IUSM Training Program is
poised to support the scientific and professional success of trainees and contribute to a diverse
and resilient biomedical workforce.

Public health relevance
Project Narrative The IUSM Graduate Division has committed significant resources and focused effort in order to increase the diversity of our applicant pool and enrolled students. The central mission of IMSD at IUSM Training Program will be to provide graduate students with a holistic training experience that enriches their technical, operational and professional skills. The specific goals of the program include to increase the number of students that obtain independent fellowships, increase PhD completion rates, decrease time-to-degree, and provide transferable curricular content.